Text and Talk: A multi-level intervention to increase provider HPV vaccine recommendation effectiveness

PROJECT SUMMARY
Understanding the factors related to for whom and why evidence-based human papillomavirus (HPV) vaccine
implementation strategies are effective and sustainable will inform the development of tailored or
complementary strategies aimed to increase health equity. Rates of HPV vaccination among adolescents in
the United States continue to remain below recommendations. Florida adolescents are particularly vulnerable
due to the state’s rank of 4th for HPV-related cancer diagnoses, but 46th for HPV vaccine initiation (≥1 dose)
and 47th for up-to-date rates (2 doses when first dose < 15 years; 3 doses when first dose ≥ 15 years). Despite
evidence of HPV vaccination disparities by geography and social determinants of health (SDOH), most HPV
vaccination implementation strategies have employed universal methods or tailored education material by
vaccine concerns and ignored the potential influence of key SDOH-related differences. Text & Talk is a 30-
clinic pragmatic trial in Florida assessing the effectiveness of two HPV vaccine implementation strategies:
(a) provider-targeted recommendation training encouraging providers to use a C-LEAR – Counsel, Listen,
Empathize, Answer, and Recommend – approach and (b) parent-targeted text messages. Text & Talk has 58
participating providers (37 trained during the study period and 21 to be trained after data collection) and 7,837
11- to 12-year-olds randomized for their parents to receive text messages about the HPV vaccine. The goal of
this proposal is to understand the factors related to for whom and why the Text & Talk implementation
strategies were effective and sustainable. For the provider-targeted training, the hypothesis is that providers
will have different experiences with implementing and sustaining C-LEAR in their practice that will guide
improvement and refinement of future trainings. For the parent-targeted text messages, text message
effectiveness is hypothesized to be differentially moderated by parental and neighborhood SDOH. Specific
aims are to: (1) Evaluate providers’ experiences with and sustainability of integrating C-LEAR into their
practice; and (2) Measure moderation of the effectiveness of a parent-targeted text message intervention on
increasing HPV vaccination by social vulnerability themes. Hypotheses will be evaluated by triangulating data
collected in Text & Talk with additional data collected during the extension period via mixed methods including
in-depth, semi-structured provider interviews, provider behavioral surveys about intent to sustain and continue
the use of C-LEAR, and spatially linking adolescent addresses to SDOH measures at census block group. The
innovations are a more in-depth focus on provider learning than previous studies and expanding existing
understanding of HPV vaccine reminder/recall moderation from primarily demographic variables to parent
factors and well-established, multicomponent risk scores measuring neighborhood-level SDOH. The
significance lies in the potential to improve the effectiveness, equity, and sustainability of HPV-related cancer
prevention implementation strategies.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it has significant promise to impact implementation strategies to increase human papillomavirus (HPV) vaccination and other health contexts where provider communication and reminder messages are important (e.g., cancer screenings and shared decision making about cancer treatments). The project maximizes the impact of the Text & Talk study by extending the findings with additional data to understand the factors related to for whom and why the implementation strategies were effective and sustainable. The proposed research is relevant to NIH’s mission to prevent cancer and eliminate disparities in cancer within the United States.